2023 Pediatric Dermatology Research Alliance (PeDRA) Annual Conference

PROJECT SUMMARY
Pediatric dermatology is a relatively young specialty that has lacked robust data about the natural history and
long-term outcomes of skin disorders that begin in infancy and childhood. In addition, evidence-based
guidelines of care, standardized treatment protocols, and FDA-approved therapies for the majority of pediatric
dermatologic disorders are sparse. The Pediatric Dermatology Research Alliance (PeDRA) was founded in
2012 to address these crucial yet unmet needs. PeDRA's primary mission is to create, inspire, and sustain
research to prevent, treat, and cure childhood skin disease. The long-term goal of PeDRA is to leverage such
research to improve the health outcomes of children with skin disorders. Annual conferences have been
integral to the success of PeDRA, providing a forum for educating investigators, identifying and prioritizing
research needs and opportunities, and developing and initiating innovative projects. A combination of didactic
lectures and panels, expert-led small group discussions, poster sessions, and unique training opportunities are
the foundation of every PeDRA Annual Conference. This proposal is for the 11th PeDRA Annual Conference,
set to take place in November of 2023 with the following aims: 1) Provide education and engagement
opportunities with a focus on patient-centricity, innovation, and cross-cutting collaboration to advance science,
while integrating equity, diversity, and inclusion across pediatric dermatology research; 2) Advance existing
research projects and develop new research priorities and initiatives in disease-areas and high-priority topics
spanning the field of pediatric dermatology; and 3) Provide a forum for the dissemination of final and ongoing
research results from a broad group of investigators to a diverse audience that includes patient stakeholders,
industry representatives, and researchers from multiple fields including potential NIH collaborators. The
expected outcomes of this conferrencer are a more developed set of research skills for current and future
physician-scientists, enhanced productivity, strengthened multi-stakeholder networks, and the conduct of high-
quality research. These activities will accelerate the pace of pediatric dermatology research, allowing clinicians
to better understand, prevent and treat skin disease in children, and giving patients and families options to
manage diseases and make informed treatment decisions in the future.

Public health relevance
PROJECT NARRATIVE Established in 2012, the Pediatric Dermatology Research Alliance (PeDRA) is a nonprofit research organization driven by the mission to create, inspire, and sustain research to prevent, treat, and cure childhood skin disease, and the PeDRA Annual Conference has been integral to the organization's growth and success since the first conference in 2013. In 2023, its eleventh annual conference will continue PeDRA's work to educate and empower physician-scientists, trainees, and other stakeholders through an agenda that disseminates results, supports the identification of high-priority questions, and facilitates science with a focus on innovation, patient-centricity, and cross-cutting collaboration. The conference will accelerate the pace of pediatric dermatology research in pursuit of PeDRA's vision of changing lives and healing children with skin disease through collaboration and discovery.